KINETICS OF UPTAKE AND EXCRETIN OF VAPORS IN MAN

The overall objectives of the proposed research are: 1) Prediction of safe exposure to noxious vapors and gases, with respect to exposure schedule, physical status of the exposed subject, physico-chemical properties of inhaled substance, and the effect of other chemical agents; and 2) design of an effective system for monitoring biological samples for evaluation of occupational exposure. Mathematical modeling will be used as a tool to achieve these objectives. Compartmental models will be used, because they afford insight into the effect of physiological parameters and physico-chemical properties of the substance on uptake, distribution, and elimination of inhaled vapors. These insights are crucial to the prediction of bio-equivalent exposures and to the monitoring and evaluating of exposure from biological samples. In our attempt to explore mathematical modeling to generate information applicable to inhalation toxicology (with special emphasis on evaluation of occupational exposure), our research is taking four courses: 1) Refinement of animal models to generate basic data, and to corroborate experimentally the predictions made by the mathematical model; 2) refinement of the existing mathematical models to accomodate the complexity of occupational exposure, and use of the model to evaluate the effect of individual factors on uptake, distribution, and elimination of inhaled vapors; and 3) simplification of the mathematical model and programming of the mathematical solution of the model for a programmable pocket calculator or microcomputer to make modeling accessible to toxicologists and hygienists for design, monitoring, and evaluation of occupational exposure; and 4) obtainment of insight on kinetics of inhalation of mixtures of vapors.